In vivo mechanisms of Dorsal-mediated transcriptional control in development

Project Summary/Abstract
The correct implementation of developmental programs depends on information encoded in an organism’s
DNA. Despite decades of work in dissecting the spatial control of gene expression in embryonic development,
we know relatively little about the temporal control of these programs—largely due to reliance on dead, fixed
tissues. Recently, our lab established new technologies for real-time measurements of input transcription factor
concentration dynamics and output transcriptional activity in single cells of the early embryo of the fruit fly
Drosophila melanogaster. These measurements have revealed that the transcriptional activity of individual
genes is not constant in time; rather, bursts of gene expression arise when promoters transition between ON
and OFF states.
Transcriptional bursting in eukaryotes, particularly in developmental genes, is ubiquitous; most transcription
factors control mRNA levels by modulating bursting frequency, duration or amplitude, or some combination
thereof. Critically, while we have uncovered which bursting parameters transcription factors modulate to dictate
transcriptional dynamics, we remain ignorant about how this control is implemented at the molecular level.
Here, we propose to make progress toward uncovering the molecular mechanisms by which the Dorsal
activator controls transcriptional bursting in the early embryo of the fruit fly Drosophila melanogaster. We will
combine our cutting-edge imaging and computational technologies for simultaneously measuring Dorsal
concentration dynamics and the instantaneous state of its target promoters (ON or OFF) in individual nuclei of
living embryos. Specifically, we will (1) use our novel compound-state Hidden Markov model to determine
whether Dorsal controls burst size, frequency, amplitude, or some combination thereof, in order to generate
hypotheses about the mechanisms of action of this activator, (2) determine whether stable clusters of high
Dorsal concentration that we recently discovered play an active role in regulating transcriptional dynamics, and
(3) use cutting-edge lattice light-sheet and adaptive optics microscopy to detect functional Dorsal binding
events at snail and determine how this binding triggers the cascade of biochemical events that leads to the
initiation and maintenance of transcription.
Overall, our proposed work will establish a clear workflow for the in vivo dissection of the molecular
mechanisms of transcriptional control in development. This approach is amenable to implementation in other
genes in the fruit fly as well as in other workhorses of developmental biology. We envision that our mechanistic
insights will make it possible to derive theoretical models of developmental decision-making that will empower
future synthetic applications as well as reengineering of multicellular organisms, for example to fix
developmental defects or to halt states of unchecked cellular proliferation in cancer.

Public health relevance
Project Narrative Although the revolution in DNA sequencing in the last 20 years has transformed our understanding of how life operates, we are still discovering the many ways that healthy and diseased states arise from how cells “decide” to make proteins from DNA sequences. The work proposed here combines experiment, theory, and computation to reveal—across scales—how these “decisions” are made through bursts of transcription in the embryo of the fruit fly, a powerful model system for developmental biology. The proposed investigations will set the stage for the predictive bioengineering of multicellular organisms and future precision therapeutic tools for repairing developmental defects and halting states of unchecked cellular proliferation in cancer.